RDCRC Administrative Unit

The Administrative Unit coordinates all UCDC activities and finances, sets general policies in collaboration with the RDCRN and ORD/NICHD, and serves as the home for the biostatistics/study design unit of the consortium that interfaces with the RDCRN Network DMCC, and for website resource development. The Administrative Unit is responsible for the ongoing evaluation of the productivity and effectiveness of regional sites, and oversees the training program. It ensures that the DSMP is implemented through the DMCC;that federal guidelines regarding inclusion of women, minorities and children are complied with;and that federal regulations (including HIPAA) and NIH policy regarding human subject projection are followed. The structure and components of the unit are described below.

Public health relevance
No PHR